Modulation of junctional signaling by BVES in colorectal carcinoma

Colorectal cancer (CRC) has a US incidence rate of almost 150,000 cases encompassing over 10% of new cancer diagnoses. In 2006 Within the Veterans Administration Healthcare System there were 4500 new cases and of those 650 were at advanced stage with very limited treatment options. Understanding the basic biology of underlying malignant transformation is critical in identifying new therapeutic targets and implementable strategies. Epithelial junctional pathology is common in malignancy. BVES is a tight junction associated protein which when suppressed induces mesenchymal transformation in human corneal epithelial cells. Further, we found decreased expression of BVES in CRC with reduced levels observed as early as adenomas indicating that its loss is an early event, likely implicating BVES in regulating additional pro- tumorigenic programs in addition to potentially contributing to metastasis. We determined the mechanism of underexpression was via transcriptional silencing via promoter hypermethylation and that this occurred in a large fraction of clinical samples, and virtually all CRC cell lines surveyed. We, and others now, have demonstrated that restoring BVES expression attenuated protumorigenic phenotypes in a variety of cancer cell lines. Collectively, this data suggests that BVES functions as a tumor suppressor in epithelial malignancy, thus BVES may represent a new diagnostic marker and/or therapeutic target in cancer. In the prior funding period, we determined that BVES was underexpressed in colitis associated carcinoma (CAC. We demonstrated the loss of BVES was functionally relevant as BVES deficient mice had increased tumor burden, and more severe dysplasia in inflammatory carcinogenesis modeling. Mechanistically, we determined that BVES interacts with and regulates the activities of PR61?:PP2A in regulating cellular c-Myc levels. Bves-/- intestine demonstrates increased stem cell markers and Bves-/- mice crossed with Lgr5-GFP reporter mice demonstrate increased Lgr5+ stem cell numbers. This is functionally relevant as Bves-/- intestine, cultured using 3D enteroid techniques, has increased plating efficiency, stem cell markers, and morphologically phenocopies ApcMin/+ tumors cultured in this system. Lastly, we have established techniques to culture, genetically modify, and establish as orthotopic xenografts, human CRC, thus developing a platform for testing whether BVES can modify the growth of established CRC and to determine the relative contribution of BVES regulated PP2A activity in the process. Much remains to be known about BVES function in epithelial malignancy. In this proposal we structure three specific aims designed to understand the role of BVES in tumor biology. First we will further our understanding of the BVES:PR61?:PP2A axis and determine whether BVES is a global regulator of PP2A activity. In the second we will use murine genetic approaches to test for BVES cooperation with Wnt in promoting tumorigenesis and determine the role of BVES in adenoma biology ex vivo. In the last aim we will test the hypothesis that restoring BVES can attenuate the growth of human Stage IV CRC and test whether restoring BVES sensitizes tumor cells to chemotherapeutics. Through these studies we will gain fundamental insight into how loss of BVES contributes to malignant progression, potentially providing evidence that supports developing BVES as a therapeutic target or diagnostic marker in colorectal carcinoma.

Public health relevance
Colorectal cancer remains the second leading cause of cancer related mortality within the United States. Because of the burden of disease associated with colorectal cancer, the VHA has issued specific directives (VHA Directive 2007-004) describing colorectal cancer screening for the VA. Despite improvements in screening approximately 4500 CRC cases are diagnosed yearly within the VA system. Unfortunately, despite improvement in screening, approximately 650 of these cases are Stage IV which represents a group of patients with abysmal prognoses. Our proposal targets a disease, colorectal cancer, which is very prevalent within the VHA and when combined with our research methodology should provide a strong fit within the VHA research portfolio. In this proposal we describe a novel tight junction associated protein which appears to function as a tumor suppressor by impairing metastasis, a feature found in Stage IV malignancy. The research outlined in this application will broaden our understanding, and Specific Aim 3 is exceptionally translational as we culture human Stage IV colon cancer and test the impact of BVES restoration in culture and in the mouse.